Development of a Total Nutrient Index

PROJECT SUMMARY
Dietary indices and scores provide a comprehensive and robust approach for nutritional exposure assessment,
especially in relation to chronic disease risk. While dietary supplement (DS) use is very common among the
U.S. population, with over 52% of adults and 33% of children routinely taking one or more (predominantly
nutrient containing) products, no existing metrics assessed intakes from DS in addition to those from the diet.
For this reason, we developed the Total Nutrient Index (TNI), a measure designed to evaluate total usual
micronutrient intakes, inclusive of intakes from foods and DS, relative to the Dietary Reference Intakes for
eight micronutrients identified as under consumed among the U.S. population by the 2015-2020 Dietary
Guidelines for Americans (DGA) in the first period of this award. We examined the relative validity of the TNI
compared to biomarkers of nutritional status among a nationally representative sample of U.S. adults and
determined that 1) the TNI is a useful metric for total micronutrient exposure assessment, and 2) that the TNI
yielded higher correlations with nutritional biomarkers when compared with those obtained from dietary intake
alone. However, with the emergence of the precision nutrition era, understanding how unique combinations of
nutrients and specific amounts of these nutrients can optimize the nutritional and health status of different
population subgroups is of utmost importance. Accordingly, in the present competing continuation proposal, we
intend to update the TNI to accommodate a life stage approach, to utilize machine learning techniques to
identify critical nutrients and in what combinations optimally benefit the health and nutrition of individuals
across the life course, and relate the TNI to risk factors, health outcomes, and mortality. In Aim 1, we plan to
develop and validate the TNI-2, an updated extension of the TNI that is tailored to different life stages and
includes nutrients and food components of

Public health relevance
PROJECT NARRATIVE Dietary supplements are an important contributor to overall micronutrient (i.e. vitamins and minerals) exposures for a large proportion of the population. We developed and validated a metric, the total nutrient index (TNI), that captures multiple micronutrient exposures inclusive of supplements for use in research, clinical, and monitoring settings. This current project will update the TNI to identify critical micronutrients and in what combinations optimally benefit the health and nutrition of individuals across the life course, and relate the TNI to risk factors, health outcomes, and mortality.